PHASE I DOSING STUDY OF SANDOSTATIN LAR GIVEN IM IN ADVANCED CANCER

Evaluate the safety, tolerability and pharmacokinetics following escalating dosing schedules of Sandostatin LAR in patients with advanced cancer.